Epidemiology

Although the global malaria burden declined steadily from 2010 to 2015, progress has since stalled. To combat
this stagnation, novel malaria control interventions have been introduced. New long-lasting insecticidal nets
(LLINs) have been developed to ameliorate the problem of increasing insecticide resistance. The newly approved
RTS,S vaccine is now being given in Malawi during the first two years of life, when disease is most severe and
potentially life threatening. Measuring the combined impact of these two interventions on the full spectrum of
malaria epidemiology (P. falciparum infection, uncomplicated clinical malaria, severe malaria disease), will
provide new information on the real-world effectiveness of both interventions, and enhance understanding of the
interplay of exposure and development of naturally acquired immunity. In this project, we will take advantage of
unique access to sites where programmatic RTS,S vaccination has been on-going for five years, and mass
distribution of dual-AI LLINs will also occur. We will build on the evaluation framework of the WHO-sponsored
RTS,S implementation trial, our prior ICEMR studies, and links to detailed entomologic surveillance in the
Transmission project. Using enhanced surveillance data from health centers and hospitals, we will quantify the
population-level effects of RTS,S vaccination and dual-AI LLINs at scale. Longitudinal and case-control data will
support more detailed investigation of individual-level impacts. All data collection will flank the 2026 dual-AI LLIN
mass distribution campaign to facilitate analysis on the effects. Investigations are proposed in 3 Aims: 1) To
measure changes in uncomplicated clinical malaria incidence, we will determine the overall and age-specific
incidence of clinical malaria using enhanced health center surveillance in health centers where RTS,S vaccine
became available in 2019, in 2022, and where vaccine has not been introduced. 2) To evaluate the impact of
RTS,S vaccination and dual-AI LLINs on P. falciparum infection and transmission, we will conduct repeated
household-based community surveys in the catchment areas of health centers with varied access to RTS,S
vaccination. Thereby, we will assess vaccine timeliness and coverage and measure prevalence of Pf infection
and gametocytemia in children aged 6-months to 10-years. 3) To assess changes in the epidemiology of severe
malaria in response to RTS,S vaccination, we will conduct hospital surveillance to measure population-level and
age-group specific incidence, and use a case-control study to quantify individual-level outcomes based on
verified vaccine status. These population and individual-level results will characterize the epidemiologic
consequences of the new interventions and be used to model their public health value at the national level.
Results will provide new insights into the effectiveness of the RTSS,S vaccine in combination with dual-AI LLINs
to prevent Pf infection, uncomplicated clinical malaria, and severe disease in the target age group, and its
potential impact on older children. Ultimately, our results will help determine the potential contribution of these
two new interventions in reestablishing progress toward malaria control and eventual elimination.